COVID Support from the IDPS to NIAID Investigators

IDPS continues to support ongoing the Vaccine Research Centers (VRC) COVID-19 studies in the establishment and continued advancement of pre-exposure and post-exposure treatment modality (i.e. vaccine) studies using the rhesus macaque animal model. As a result, IDPS personnel were co-authors on two (2) scientific manuscripts published in peer-reviewed scientific journals, accepted for publication, and/or in the review process. The majority of COVID work was suspended when the vivarium shut for repairs.